A Pilot Feasibility Trial of a Tailored Intervention to Improve Adherence in Adolescents and Young Adults with Cancer

PROJECT SUMMARY/ABSTRACT
Up to 60% of adolescents and young adults (AYAs) with cancer are non-adherent to cancer treatment
medications and thus at an increased risk of relapse and death. In response, multiple professional
organizations have endorsed medication adherence promotion as a standard of pediatric cancer care and a
critical component of AYA oncology programs. Improving adherence, however, has proved difficult as barriers
to adherence differ across AYAs and each barrier requires a different set of behavior change techniques
(BCTs). Despite this need for tailoring, the two adherence-promotion interventions including AYAs with cancer
to date have taken a “one-size-fits-all” approach and produced non-significant or small treatment effects. This
leaves a critical gap between the recommended standards of care and available interventions to improve
adherence.
The proposed research hypothesizes that delivering an intervention in which BCTs are tailored to address a
given AYA’s top barriers may hold promise for improving adherence among AYAs with cancer. Directly aligned
with PAR-19-309’s call for “novel strategies to improve cancer-related health behaviors [i.e., adherence],” the
purpose of the proposed research is to conduct a pilot feasibility test of a tailored adherence-promotion
intervention for AYAs with cancer. The proposed research also directly responds to the National Cancer
Institute’s current special interest in grants that “test innovative interventions...to optimize patient treatment
regimen adherence” (NOT-CA-20-026).
A pilot feasibility randomized clinical trial comparing this tailored intervention to uniform standard of care will be
conducted. A total of 40 AYAs with cancer from 3 sites will be randomized to the tailored adherence-promotion
intervention or uniform standard of care. Data will be collected to explore the hypotheses that the intervention
meets pre-established enrollment, retention, fidelity, and data completion feasibility criteria and that AYAs will
rate the intervention as easy to use and acceptable. Exploratory analyses will be conducted to evaluate
potential group differences in electronically-monitored medication adherence. Findings will be used to inform
subsequent phases of intervention development and testing.

Public health relevance
PROJECT NARRATIVE Medication non-adherence is hypothesized to be a primary cause of treatment failure, mortality, and the age- related disparities in survival improvement faced by adolescents and young adults with cancer. The proposed research responds directly to the National Cancer Institute’s calls for efforts to improve adherence by pilot testing a tailored adherence-promotion intervention for adolescents and young adults with cancer. The novel intervention resulting from the proposed research will have the potential to transform current approaches to adherence-promotion and improve the health and quality-of-life among thousands of adolescents and young adults with cancer who may struggle with non-adherence.